Alcohol-induced changes in protein acetylation: mechanisms and consequences

SUMMARY
More than 22,000 people each year die of alcoholic liver disease in the US alone with estimates as high as 3.3
million deaths each year globally (5.9% of all global deaths). So clearly, alcoholic liver disease is a major
biomedical health concern world-wide. Because the liver is the major site of ethanol metabolism, it is the most
susceptible organ to alcohol-induced injury. Although the progression of alcoholic liver disease is well-described
clinically, the molecular basis for alcohol-induced liver injury is not understood. This proposal expands on our
findings that microtubules are more highly acetylated and more stable in ethanol-treated WIF-B cells, liver slices,
livers from ethanol-fed rats/mice - and from our preliminary data - also in human liver tissue. We have further
shown that microtubule hyperacetylation directly explains alcohol-induced defects in protein trafficking and lipid
droplet dynamics. In this proposal, we will test the broad hypothesis that ethanol-induced protein modification
differentially disrupts microtubule-based protein/organelle motility that leads to peroxisome dysfunction
and promotes alcoholic steatosis. We will also test the hypothesis that supplementation with caloric
restriction mimetics protects against injury. Our findings that both microtubule acetylation and acetaldehyde
adduction impair protein trafficking to similar extents suggest both modifications contribute to the impaired
motility observed in ethanol-treated cells. We will examine how microtubule modifications (and modifications on
other proteins) differentially impact protein and organelle dynamics in Aim 1. In Aim 2, we expand our studies
on altered organelle motility to peroxisome dynamics. Despite their known role in regulating oxidative stress and
fatty acid metabolism, peroxisomes are under-studied in their contribution to the progression of alcohol-induced
steatosis. Emerging evidence indicates that microtubules and associated motors are important regulators of
peroxisomal dynamics, and by extension, their function – a relationship we will explore in the context of alcohol-
induced steatosis. Aim 3 takes us in an exciting direction where we expand on our studies with spermidine on
its hepatoprotective effects against fibrosis. Spermidine and hydroxycitrate (caloric restriction mimetics) induce
protein deacetylation (including microtubule deacetylation) by different mechanisms. Thus, in Aim 3 we propose
that this enhanced protein deacetylation will counteract alcohol-induced global protein acetylation (and alcohol-
induced microtubule-dependent protein trafficking) to confer hepatoprotection. We further propose that
spermidine promotes cytoprotective autophagy thereby decreasing the levels of accumulated lipid droplets and
dysfunctional mitochondria and peroxisomes. In general, studies will be initiated in polarized, hepatic WIF-B
cells, confirmed in livers from ethanol/high fat diet-fed mice, and where possible, confirmed in human tissue. We
have garnered the support of several others to provide their expertise to the project. We have continued access
to the Imaging Facility located at nearby Johns Hopkins Institute of Basic Biomedical Studies and are members
of the Hopkins GI Center allowing us access to many services and resources. The expansive expertise of our
collaborators, the access to high-end resources coupled with our considerable expertise in hepatic cell biology
situate us perfectly to perform these important mechanistic and translational studies.

Public health relevance
NARRATIVE More than 22,000 people each year die of alcoholic liver disease in the US alone with estimates as high as 3.3 million deaths each year globally (5.9% of all global deaths). So clearly, alcoholic liver disease is a major biomedical health concern world-wide. We are poised to identify novel mechanisms leading to alcohol-induced liver injury and are testing novel therapeutics based on our recent findings.